Defining the Role of Platelet ABO(H) Blood Group Antigens in Hemostasis and Thrombosis

PROJECT SUMMARY/ABSTRACT
Approximately one in three deaths results from hemorrhage (bleeding) or thrombosis (blood clots). ABO
blood type is a major risk factor for hemorrhage or thrombosis. Type O individuals are at higher risk for bleeding
than those with non-O blood types. Conversely, non-O individuals are at higher risk of thrombosis. The reason
that blood type O is associated with a higher risk of bleeding and lower risk of thrombosis is incompletely
understood. Several recent publications have suggested that differences in platelet function contribute to the
increased bleeding risk in type O vs non-O individuals.
Despite the clinical importance of ABO type as a risk factor for thrombosis and hemorrhage, the mechanism
by which platelet ABO(H) blood group antigens impact hemostasis and thrombosis remains
uncharacterized. Our central hypothesis is that ABO(H) antigens on functionally relevant platelet membrane
glycoproteins impacts their binding to ligands. I will test this hypothesis via the following aims:
AIM 1. Define the impact of ABO(H) glycans on platelet binding to Von Willebrand Factor (VWF). Our
working hypothesis is that GPIb⍺ that is decorated with A or B antigen containing O-glycans will exhibit enhanced
binding to VWF compared with type O(H) GPIb⍺. We will use enzyme-linked immunosorbent assays (ELISA)
and surface plasmon resonance to quantify the binding kinetics of VWF to platelets of blood types O, A, B, and
AB.
AIM 2. Identify ABO(H) antigen carrying glycoproteins on platelets using a click chemistry enrichment
strategy and mass spectrometry proteomics. Our working hypothesis is that there are dozens of functionally
relevant platelet glycoproteins that carry the ABO(H) blood group antigens. We will use an innovative click
chemistry strategy to selectively enrich H antigen carrying glycoproteins from platelet lysates, and identify these
proteins using mass spectrometry proteomics. We will validate these hits using western blot, glycomics, and
glycoproteomics.
The successful completion of this project will provide mechanistic insight into how platelet ABO blood type
affects binding to VWF and a comprehensive inventory of the glycoproteins and glycans on the platelet surface
that carry ABO(H) antigens. This will provide unprecedented insight into platelet-intrinsic mechanisms
underlying the well-known epidemiologic association between ABO blood type and risk of bleeding and
clotting. This work will fill a critical knowledge gap in our understanding of why ABO blood type is associated
with risk of bleeding and clotting, and provide a molecular framework that will facilitate future development of
diagnostic tests and therapies to better predict, prevent, and manage thromboembolic disease and hemorrhage.

Public health relevance
PROJECT NARRATIVE ABO blood type is an important risk factor for bleeding or thrombosis (blood clots). Little is known about how ABO blood type impacts the function of platelets, which are critical in mediating the balance between bleeding and clotting. The aim of this proposal is to determine which platelet proteins are decorated with the sugars that define the different ABO blood types, and how these modifications impact platelet function.